Identification of serological markers of protection and risk for dengue vaccines and natural infection

Project Summary
Dengue remains stubbornly endemic in many countries. Vaccine development efforts have been hampered by
a poor understanding of the immune response. We do know that pre-existing immunity from vaccination or
historic infections is key to driving disease risk, however, accurate markers of risk or protection are lacking,
including how they change over multiple years. Less is known about the role of non-neutralizing antibody
functions, such as antibody-dependent cell cytotoxicity, and antibody-dependent enhancement in driving disease
risk. Neutralizing and non-neutralizing antibody responses have not been characterized alongside cellular
immune responses that have been identified to be associated with risk of illness. Here, we will expand upon
previous work on the diversity of neutralization responses to specifically add characterization of non-neutralizing
antibody responses and cellular immune responses from natural infection and vaccination using samples taken
from the same individuals over numerous time points. These samples come from cohorts that had regular
collection of sera and PBMC and were followed for instances of infection and illness, many of which severe. This
includes a cohort of individuals that were vaccinated by the only licensed dengue vaccine, a cohort followed for
13 years. We also have access to samples from individuals vaccinated with another candidate vaccine followed
over five years. Finally, we will re-recruit cohort participants to provide samples 23 years after their participation
to investigate long term responses after infections. We will measure multiple non-neutralizing and neutralizing
responses to a diverse set of dengue viruses a wide range of antibody measures as well as a limited set of
cellular immune responses, providing a multi-dimensional, systems characterization of humoral and cellular
immune responses. We will use this multi-dimensional measure and mathematical models to reconstruct full
infection histories and immune dynamics. These efforts will provide a set of correlates of protection/risk of illness
and infection that can be used to assess risk in vaccine trials and epidemiological studies. These mechanistic
models will be generally useful to infer dynamics of immune responses to antigenically variable pathogens and
can be used to assist in the design and analysis of vaccine trials and epidemiological studies.
Relevance to Public Health
Multiple candidate dengue vaccines are currently in development, however, their likely effectiveness over short
and long time periods remain unknown due to a lack of good markers of protection or risk. Identifying such
markers, and how they change over time is critical to their optimal use, continued efficacy and population safety.
More broadly, characterization of non-neutralizing antibody and cellular immune responses to a diverse set of
dengue viruses alongside neutralizing responses in humans followed over many years who have experienced
dengue infection and/or vaccination will increase our understanding of immune responses to dengue.

Public health relevance
Dengue vaccine development and evaluation is challenged by a lack of immunological correlates of protection and risk. A continued lack of understanding of durable protective immunity and, perhaps a more acute need, immune profiles that present increased risk threatens to present another failure of evaluation of current dengue vaccine candidates. Here, we propose to capture the diversity of non- neutralizing antibody and cellular responses from infection and vaccination alongside neutralizing responses to develop a better understanding of immunity and risk of dengue infection and illness.